Partnership for advancing cervical cancer prevention in women living with HIV (CASCADE - Research Hub)

PROJECT ABSTRACT
The overarching goal of the “Partnership for Advancing Cervical Cancer Prevention in Women Living with HIV”
is to improve the cascade of cervical cancer prevention for women living with HIV (WLWH) including increasing
uptake of cervical cancer screening services, improving management of screen positive women, and optimizing
precancer treatment outcomes, particularly in resource-constrained settings. Research base members have
established collaborations with a history of conducting successful clinical trials and impacting clinical care. As a
CASCADE Research Base, we will provide impactful scientific and statistical direction for pragmatic clinical trials
to be conducted at the CASCADE Clinical Sites.
We will establish a central administrative infrastructure to facilitate the conduct of three pragmatic trials. The
proposed trials will include an investigation of primary HPV screening to facilitate uptake of cervical cancer
screening, triage strategies for women who screen positive with high-risk HPV, and adjunctive treatment to
improve outcomes to cervical pre-cancer treatments. We will also provide opportunities for early-stage
investigators to develop clinical research skills within CASCADE.
We have administrative expertise and experience in operationalizing international clinical trials and supporting
clinical research sites in the timely implementation of projects. Our highly experienced investigators and our
proposed trials will be of substantial benefit to the CASCADE network and the shared goal of eliminating cervical
cancer in WLWH.

Public health relevance
The overarching goal of the “Partnership for Advancing Cervical Cancer Prevention in Women Living with HIV” is to improve the cascade of cervical cancer prevention for women living with HIV (WLWH) including increasing uptake of cervical cancer screening services, improving management of screen positive women, and optimizing precancer treatment outcomes, particularly in resource-constrained settings. Partnership members have established collaborations with a history of conducting successful clinical trials and impacting clinical care. As a CASCADE Research Base, we will provide impactful scientific and statistical direction for pragmatic clinical trials to be conducted at the CASCADE Clinical Sites.